PORT (Portland Oral health Research Training)

Project Summary/Abstract
The Portland Oral Health Research Training (PORT) Program is a comprehensive research-training program built on our
successful history of research training and mentoring at the Oregon Health & Science University School of Dentistry
(OHSU SOD). This program is leveraged on our creative, collaborative and collegial basic and translational research
scientists using innovative, integrated, and interdisciplinary approaches to address the critical issues in oral health
research and research workforce needs facing our nation. This new application is bolstered by several important aspects,
including our recent experience with a new DMD/PhD program, our strong NIDCR support in microbial sciences,
biomaterials/tissue engineering/regenerative medicine, and clinical and translational research, which includes prestigious
R35 awards to two outstanding mid-career investigators within the SOD, an active campus-wide research training
environment supported by dozens of NIH funded training grants, and a large pool of research-experienced
undergraduates from partner institutions, Portland State University and Oregon State University, housed in the same new
research and education building as the OHSU SOD. The experience accumulated from these scholarly activities and
partnerships across Oregon has led to this innovative program designed to enhance the interests and knowledge of dual
degree students, graduate students, and postdoctoral fellows and visiting foreign-trained dentists, in basic, translational
and clinical research. The PORT creates a structured path forward to productive, independent academic oral health
research careers. Integrative school-based, university-wide core PORT scholarly activities, and across campus ongoing
academic events, including the SOD’s Dean’s Seminar Series, OHSU Research Week, Pre-matriculation DMD Students’
Research Fellowship, Student Research Group seminars and events, fellowships for undergraduate and postdoctoral
research, and courses in Mentorship, Scientific and Grant Writing, Public Speaking and Presentation Workshop, and
Leadership Training Opportunities, are key to the PORT training experience The 5-year PORT Program offers four
complementary training paths to maximize its effectiveness: Track I - DMD/PhD with one position requested in year 1 and
another position required from year 2 on; Track II - Pre-doctoral Ph.D. with one position throughout the funding cycle;
Track III - Post-doctoral training with two emphasis sub-tracks: A) a traditional post-doctoral experience, and B) a Master’s
of Science degree in Clinical & Translational Research, three positions requested for year 1, and 4 positions for year 2 on;
and Track IV - Pre-doctoral Ph.D. or Postdoctoral training for foreign-trained dentists with one position in Year 1, and an
additional position added from Year 2 on. The PORT is intended to accelerate the transition of highly motivated qualified
candidates into independent oral health researchers in a collegial, multi-faceted academic environment.

Public health relevance
Public Health Relevance The OHSU SOD is uniquely positioned to offer this comprehensive research mentoring and training PORT for the next generation of oral health scientists since we are the only dental school in the state of Oregon, supported by robust OHSU and state-wide research and research training resources. We are committed to addressing current and future shortages in the oral health research workforce by preparing a multi-skilled and accomplished cadre of individuals for careers as independent scientists. Our objective is consistent with NIDCR’s mission to advance national research needs in dental, oral and craniofacial health and science.